Molecular mechanisms that regulate vesicle formation and transport

PROJECT SUMMARY
How the intracellular membrane system of eukaryotic cells is configured and maintained is a fundamental
problem in cell biology. Deficiencies in this organization often lead to disease. The overarching goal of my
laboratory is to define the molecular mechanisms that regulate membrane dynamics, including vesicle
biogenesis, organelle trafficking, and protein sorting in the early secretory and endocytic pathways of mammalian
cells. We aim to determine how normal membrane transport contributes to cellular homeostasis and to
understand the molecular basis for disease states that emerge when trafficking pathways are disrupted. Using
a combination of model systems, structural biology, biochemistry, genetics, and high-resolution subcellular
imaging, our studies focus on two essential trafficking pathways necessary for protein and lipid export from the
endoplasmic reticulum (ER) and protein turnover within lysosomes via a multivesicular endosome (MVE)
intermediate. Mutations in several factors that regulate these processes have been implicated in cancer,
diabetes, immune dysfunction, and neurodegeneration. Thus, deciphering the fundamental principles underlying
the regulation of ER export and MVE biogenesis should facilitate the future identification of therapeutic targets
for disease intervention. One major focus of my research has been elucidating how the early secretory pathway
is organized. Our findings revealed the existence of a conserved membrane interface, which links subdomains
on the endoplasmic reticulum (ER) that produce COPII transport intermediates to juxtaposed ER-Golgi
intermediate compartments (ERGIC). Importantly, we have also identified several regulatory factors that act at
this interface to control the efficiency of secretory cargo egress from the ER. My second research focus is aimed
at understanding the mechanisms that direct the formation of MVEs, which bud intralumenal vesicles (ILVs) into
their interior to sequester membrane-associated cargoes from the cytoplasm. Eventual fusion of MVEs with
lysosomes results in the degradation of ILVs and their associated proteins, which plays a key role in tumor
suppression by governing the capture and sequestration of signaling receptors. Over the past several years, we
have focused on identifying regulatory mechanisms that enable components of the endosomal sorting complex
required for transport (ESCRT) machinery to efficiently sort ubiquitin-modified cargoes into ILVs. In this renewal
application, we will capitalize on evolving methodologies to further establish how COPII-mediated transport and
ESCRT-mediated MVE biogenesis are properly regulated. A better understanding of these processes will yield
key insights into the homeostatic controls that sustain normal protein trafficking in the secretory and endocytic
pathways during cell proliferation and differentiation.

Public health relevance
PROJECT NARRATIVE The directed movement of proteins and membranes between different cellular locations is a fundamental process required for the proper functioning of all eukaryotic cells. Many diseases including cancer, neurodegenerative disorders, diabetes, and immune dysfunction can be caused by intracellular protein transport defects. The proposed research will determine how membrane trafficking pathways are appropriately regulated, enhancing our fundamental understanding of this process, which should facilitate the future identification of therapeutic targets for disease intervention.